A Circuit Mechanism for the Development of Cortico-cortical Connectivity

Project Summary
In the cerebral cortex, gamma-aminobutyric acid (GABA)ergic interneurons are the major source of inhibition.
Interneuron dysfunction is strongly associated with autism and childhood epilepsy. We demonstrated that
environmental influences such as electrical activity are fundamental for the maturation of GABAergic circuits.
However, the identity of the activity patterns controlling interneuron development remains poorly understood.
The long-term goal of this research is to uncover how early interneuron dysfunction leads to lasting
neuropathologies. The objective of this proposal is to reveal the signaling pathways underlying activity-
dependent development and to assess how perturbations in this process lead to aberrant brain function.
To this end, we will use the murine barrel cortex as a well-established model for the study of activity-dependent
circuit maturation. We will focus our studies in superficial circuits since our previous work indicates that these
circuits are exquisitely sensitive to environmental perturbations in the neonate. In the near term, this proposal
is aimed at investigating the role of specific interneuron subtypes in regulating the emergence of long range
connectivity (Aim 1). In addition, this project will determine the role of GABAergic inputs for the functional
maturation of pyramidal networks. We will study the role of Gabrb3, a gene encoding for the beta3 subunit of
GABAA channel. Mutations in this gene are strongly associated with Angelman syndrome and ASD (Aim 2).
Finally, we will assess how developmental defects in early GABAergic signaling lead to abnormal brain activity
in cortico-cortical pathways during development (Aim 3).
With respect to the outcomes, our work is expected to identify basic mechanisms fundamental for the
emergency of a healthy E/I balance. In addition, these results are expected to have a significant translational
impact because they will expand our mechanistic knowledge on how mutations in the GABRB3 gene may lead
to behavioral abnormalities frequently observed in ASD patients.

Public health relevance
GABAergic dysfunction is strongly associated with autism, schizophrenia and childhood epilepsy. Increasing experimental evidence points towards imbalances between the excitatory and inhibitory circuits in the brain as a prominent component in the etiology of these illnesses. This project is aimed at further our understanding on how electrical activity affects early brain maturation during critical periods of development with an emphasis on cortico-cortical pathways.